Developing a novel disease-targeted anti-angiogenic therapy for CNV

Project Summary
Wet age-related macular degeneration (AMD) is a leading cause of vision loss in the elderly in developed
countries, characterized by choroidal neovascularization (CNV). The disease is currently treated by anti-vascular
endothelial growth factor (VEGF) drugs, such as aflibercept, but with limited efficacy and potential side effects.
An unmet clinical need for wet AMD therapy is to identify disease-restricted angiogenic factors and develop novel
VEGF-independent disease-targeted anti-angiogenic therapies with optimal safety for alternative or combination
treatment to improve the efficacy for anti-VEGF-resistant patients. We applied our innovative technology of
comparative ligandomics to CNV and healthy mice and discovered a novel CNV-selective angiogenic factor that
selectively binds to CNV but not healthy choroidal vessels. In contrast, VEGF indiscriminately drives
angiogenesis. Preliminary data showed that polyclonal antibodies (pAbs) against the CNV-selective angiogenic
factor alleviate CNV in mice with comparable efficacy to aflibercept. However, lack of a neutralizing monoclonal
antibody (mAb) against this novel target is a major obstacle to develop disease-targeted anti-angiogenic therapy
for clinical translation and assess the efficacy and safety. The objective of this exploratory project is to generate
and characterize neutralizing mAbs against the new target. Our central hypothesis is that the neutralizing mAbs
against the angiogenic factor efficiently alleviate CNV with high efficacy but minimal adverse side effects to
healthy retinal vessels and neurons. In Aim 1, we will generate mAbs against the angiogenic factor and
characterize their neutralizing activity. In aim 2, we will characterize the therapeutic efficacy and safety of the
neutralizing mAbs. To our knowledge, all anti-angiogenic drugs, approved or in the pipeline, target conventional
angiogenic factors that indiscriminately regulate both diseased and healthy vasculatures. This project has the
potential to develop a novel disease-targeted VEGF-independent anti-angiogenic therapy for wet AMD with
minimal side effects on healthy retinal vessels and neurons. Successful development of this novel therapy will
also support the innovative ligandomics technology that is broadly applicable to vascular and non-vascular
diseases for pathological mechanism research and drug target discovery.

Public health relevance
Project Narrative Wet age-related macular degeneration (nAMD) is a leading cause of blindness in elderly Americans and is currently treated by drugs against a conventional angiogenic pathway that regulates both diseased and healthy vessels with limited efficacy. We recently discovered a novel angiogenic factor that exclusively regulates diseased vessels in nAMD without detectable binding to healthy vessels. This project is to develop therapeutic monoclonal antibodies against this target, investigate the efficacy and safety of this novel therapy and assess the potential for develop the novel therapy for wet AMD.